Telerehabilitation Combining Virtual Reality Adaptable Games and Drug Therapy for Early Alzheimer's Disease

PROJECT SUMMARY Objectives: The first objective is to develop a computer-based cognitive training system for individuals in the early stages of Alzheimer’s Disease. The product, a home-based custom Virtual Reality (VR) system will be developed, targeting cognitive domains (processing speed, executive functions, attention, language, memory) as well as depression. The system will incorporate a novel low-cost biosensor device. Usability and feasibility studies of the product will determine technology ease of use, acceptance and clinical benefit. Specific Aims: 1) Development, validation and usability evaluation of an integrative therapy system; 2) RCT Feasibility study on individuals with cognitive impairments due to Alzheimer’s Disease, who may also be depressed. Methods: 1) Develop a system to detect cognitive load variation during computer interaction; 2) Develop VR-based therapeutic games with focus on cognitive intervention; 3) Develop communication software to allow remote management of the game system with training data transfer; 4) Conduct validation on n=2, and a usability study n=4 (2 healthy and 2 with AD); 5) Conduct an RCT feasibility trial with cross-over design, n=28 participants with AD and their 28 caregivers. Participants will be randomized equally into experimental and wait-list controls. Caregivers will log training issues and perceived value of training; 6) Sample standardized outcome measures at baseline, mod- and post-therapy. 7) Analyze adherence to protocol and outcome data using descriptive and multivariate regression analysis to determine cognitive benefits and group changes, when combined with customary care. NIH Relevance: Current medication treatments for cognitive impairments subsequent to AD benefit from addition of physical exercise. The proposed home-based cognitive intervention is an innovative approach, provided in the convenience of home. This increases access to care with less caregiver burden.

Public health relevance
8. PROJECT NARRATIVE Public Health Relevance: Current medication-based treatments for Alzheimer’s Disease are largely ineffective [Cummings et al., 2014]. The proposed intervention is an innovative approach provided in the convenience of the home.